Non-Coding Genetic Vulnerabilities in Human Photoreceptor Function and Disease

PROJECT SUMMARY/ABSTRACT
Cis-regulatory elements (CREs) are critical sites within the non-coding genome that orchestrate the expression
of genes necessary for normal cellular function. Mutations within CREs contribute to human diseases including
disorders of vision. Over the past funding period, our group identified and characterized CREs in the adult and
developing retina using single-cell, epigenomic, machine learning, and genetic approaches and used these data
to elucidate genetic causes of unsolved visual disorders. Despite this progress, the function of most of retinal
CREs and the features that define essential CREs remain unknown. This gap in knowledge is a significant
obstacle toward understanding the genetic regulation of normal human vision, identifying disease-causing
mutations, and developing corrective strategies. The long-term goal for our research is to decipher how non-
coding genetic variation shapes the structure, function, and diseases of the retina and to advance therapeutic
approaches. The focused objective of this proposal is to improve high-throughput approaches to study retinal
CRE function at scale, to identify CREs that are necessary for retinal photoreceptor development, function, and
survival, and to identify predictive features of essential CREs. The central hypothesis driving this work is that
higher-throughput techniques will identify essential CREs and will reveal the critical features that impart their
function. To test this, we have developed a multiplexed approach to disrupt multiple retinal CREs in parallel and
measure the effect on gene expression, cell state, and survival. We complement this approach by using a
convolutional neural network-based machine learning approach to predict CRE function. Lastly, we are utilizing
powerful new genetic models to identify CREs that control the timing of human and mouse retinal development.
The contribution of this research will be to elucidate the features and mechanisms by which CREs regulate genes
that are necessary for human photoreceptor function and survival. This will enable the systematic identification
and interpretation of disease-associated variants within CREs and improve genetic diagnostics for retinal
disease. By opening up the non-coding genome to functional analyses, it will be possible to develop new
therapeutic strategies for correcting or preventing inherited retinal diseases.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health as it will elucidate key mechanisms that underlie the function of the human retina and will enable diagnosis of visual disorders that currently have unknown genetic origin. The research will achieve this objective by characterizing functional regions of the genome that are essential for vision, but that are currently not well understood. The novel insights gained by completion of this study will immediately facilitate the discovery and interpretation of regulatory elements within the genome and accelerate the development of therapies to treat visual disorders that affect people of all ages.